RESPIRATORY VIRUSES IN VOLUNTEERS

A live attenuated bovine parainfluenza type 3 virus was infectious, non- reactogenic, and restricted in replication in eight human seronegative humans. It induced a serum antibody response against the human PIV3 and thus continues to show promise as a vaccine candidate. The cold passaged mutant (cp45) of the JS wild type PIV3 was previously found to be safe in adults, seropositive children, and seronegative chimpanzees. Studies were initiated in seronegative infants and young children at a dose of 104.0 pfu and the very limited data that has been obtained to date indicates that the virus is attenuated and infectious. Influenza A virus heterosubtypic immunity (i.e., immunity induced by infection with one subtype of influenza A virus that is active against a virus belonging to another subtype) did not appear to be sufficient to affect the infectivity, immunogenicity, or replication of an attenuated influenza A virus vaccine in infants and young children. These observations confirm the weak nature of heterosubtypic immunity in humans, and suggest that it will not limit the utility of live attenuated influenza A viruses in young children. Studies with live attenuated cold-adapted influenza A virus vaccine in infants less than six months of age were initiated. A dose of 106.0TCID50 was safe in this age group and about 40% of vaccinees could be reinfected with vaccine within two months of vaccination.